CANCER INFORMATION SERVICE (REGION 12)

The Cancer Information Service (CIS) of Indiana and Michigan is one of nineteen regional offices supported by the National Cancer Institute. CIS of Indiana and Michigan is a program of and located at the Michigan Cancer Foundation-Prentis Comprehensive Cancer Center in Detroit. Outreach to Indiana is facilitated through a cooperative agreement with the Cancer Center at Indiana University in Indianapolis. Each CIS office is responsible for implementing three primary activities in the community. These include: l) operating a toll free phone service; 2) developing local resource directories of cancer-related services and programs in their service area; and through its outreach program 3) promoting NCI cancer education initiatives in the region and providing technical assistance for outreach activities to support those initiatives. Through the toll-free phone service (1-800-4-CANCER), the CIS provides accurate, up-to-date information on cancer to patients and their families, health professionals and the general public. Through the outreach program, the CIS serves as a resource for state and regional organizations by providing printed materials and technical assistance for cancer education, media campaigns, and community programs.